Deciphering the single-nucleus genomic regulatory structure of opioid use disorder in the human brain

Project Summary
Opioid use disorder (OUD) has reached epidemic levels in the Unites States, associated with increased rates of
hospitalization and drug overdose death, the latter showing a significant steep rise of up to 29.4% in 2020.
While genetic risk factors have been identified in recent large-scale genome-wide association studies (GWAS)
of OUD, these explain only part of the variance and often map to noncoding regions. Epigenetic modifications
have been implicated in the etiology of opioid use disorders (OUD) underlying the gene and environment
interplay. We and others have found that alterations of DNA methylation (5mC), one of the most studied
epigenetic mechanisms, is associated with OUD in both human peripheral and postmortem brain. However,
most of this work has been done in bulk tissues, which obscures the functional role of the cellular diversity in
human cells. Further, research is needed to assess additional and novel epigenetic regulatory layers to gain a
better understanding of its contribution to gene regulation and its ability to interpret the functionality of GWAS
genetic variants in the context of OUD. Here, I offer a novel framework to tackle these gaps and challenges: 1)
conduct a simultaneous profiling of DNA methylation, DNA hydroxymethylation, and 3D genome structure in
single human nuclei, 2) identify OUD-dependent regulatory signatures within cell types and brain regions, 3)
evaluate the crosstalk between the different epigenomic regulatory layers, and 4) construct gene programs to
finely map OUD GWAS variants and polygenic signals to function. This comprehensive single-cell multiomics
mapping of OUD will examine the dorsolateral prefrontal cortex (DLPFC), amygdala (BLA), and nucleus
accumbens (NAcc), part of the addiction circuitry, of human postmortem brain samples collected from the
UTHealth Brain Collection datasets and using the VA Brain Bank (NPBB) as a validation cohort. This work is
highly innovative and will open new lines of research the genetics and epigenetics of OUD by providing novel
mechanistic insights on its gene regulatory structure in the human brain. This proposed study will identify and
help inform molecular targets to be used as prevention and treatment efforts for individuals suffering from
OUD.

Public health relevance
Project Narrative The goal of the proposed project is to better understand the molecular underpinnings and cell diversity of opioid use disorder in the human brain. This study will conduct a joint profiling of methylomics, hydroxymethylomics, 3D chromatin structure, and transcriptomics of OUD in single nuclei from human postmortem brain to identify molecular targets that may inform prevention and treatment efforts.